Sex Differences in T cell metabolism

Abstract
Sex is an important biological variable as it has dramatic impacts on health and disease. Males have a greater
risk for infection and severe outcomes, while females have increased incidence of autoimmunity. This is often
attributed to sex differences in the immune system, as females have higher numbers of activated T cells with
more potent cytotoxic activity than males. Despite these differences, biomedical research has historically used
males only and many studies still do not stratify for sex. As a result, the biology underlying sex differences in
disease is poorly understood. As many discovered pathways in diseases may only be relevant to one sex, this
results in new therapeutics that are not always appropriate for both sexes. Thus, the need to understand the
major driving mechanisms for sex differences in immunity is urgent. Metabolism is a major biological factor with
significant sex differences. At the systemic level, there are fundamental metabolic differences between the
sexes, such as in fuel utilization, lipid metabolism in liver and adipose, and core body temperature. Cellular
metabolism is heavily influenced by systemic metabolism, yet little is known about sex-specific immune cell
metabolism. Cellular metabolism dictates the fate and function of immune cells as it powers all immune cell
functions but also metabolites act as signaling molecules and building blocks for effector molecules. Thus, we
hypothesize that there are sex differences in immune cell metabolism, which may be related to sex
differences in systemic metabolism, and these in turn influence disease outcome. Further, such
differences are likely driven by sex hormones and/or chromosomes. The specific aims to address this
hypothesis are 1) to assess sex differences in T cell function and metabolism and 2) to investigate the
contribution of sex hormones versus sex chromosome complement to these putative differences in the context
of viral infection. Key metabolic pathways that have sexually dimorphic expression in CD8+ and CD4+ T cells
will be uncovered via imaging, untargeted metabolomics, flow cytometry and Seahorse following T cell specific
or viral-induced activation in vivo. To study the mechanism behind sex-biasing factors modulating T cell
metabolism we will use the sex-reversed “four core genotype” mouse model and sex hormone receptor knockout
mice. These proposed studies will provide a mechanistic basis of sex differences in T cell metabolism following
activation and during viral infection. Understanding fundamental sex differences in T cell metabolism and the
sex-biasing factors that modulate them will provide a basis for future sex-specific therapeutics. My research
passion for the last 5 years has been to study sex differences. Now, this F31 training plan, coupled with the
research plan and the support of my Sponsor in the invigorating and collaborative research environment at
Harvard, will prepare me for my longer-term goal of an independent academic career combining the field of
immunometabolism and sex differences.

Public health relevance
Project Narrative It has long been observed that disease severity and outcomes are different in males and females, yet we don’t know why. The goal of my proposed project is to answer this question by looking at differences in T cell metabolism between males and females, and how they relate to viral infection outcomes. Understanding the biology of sex differences in T cells, metabolism, and infection will offer context to sex differences in immunity as well as new sex-specific therapies for infection.